Home Food Delivery for Diabetes Management in Patients of Rural Clinics

ABSTRACT
Approximately 30 million (~9%) of all people in the US have type 2 diabetes (T2DM),1 and this number is
expected to continue to rise.2 At the same time, 15 million (11.8%) US households experience food insecurity,3
defined as lack of access to adequate amounts of healthy food. T2DM and food insecurity are strongly related
for U.S. adults: Very low food security is associated with an over 100% increase in T2DM prevalence
compared with adults from high food-secure households.4 Residents of rural areas are particularly threatened
by the intersection of food insecurity and T2DM. Food insecurity prevalence in rural areas is 1.2 times higher
than in metropolitan areas.6 T2DM prevalence in rural areas is 17% higher than in metropolitan areas.7 Recent
studies have shown promise for improving health indicators for food insecure people with T2DM. These studies
have tested interventions distributing healthy food and shown preliminary indications of success for improving
glycemic control, diabetes distress, self-reported diabetes management, and food security.22-24,29 We will test
this approach for the first time in rural areas in a way that both promotes participant adherence and is scalable:
we will employ home-delivery of T2DM-appropriate food boxes with evidence based-educational materials and
recipes to improve glycemic control and diet quality of rural food insecure patients with T2DM. This intervention
adopts a health equity framework:30,31 it addresses specific needs and barriers of rural food insecure
households at risk for many health and economic disparities. Our long-term goal is to transform rural residents'
management of T2DM.This study's objective is to determine the effectiveness of an intervention that is
scalable and sustainable and promotes patient adherence by mitigating rural food insecure participants'
difficulties associated with completing existing interventions. Our specific aims are: 1. Compare the
effectiveness of the Healthy Food Delivery Intervention (HFDI) plus standard care and standard care alone to
improve diabetes-related outcomes among rural food insecure patients with T2DM. 2. Compare the
effectiveness of the HFDI plus standard care and standard care alone to improve diet quality among rural food
insecure patients with T2DM. 3. Compare cost-effectiveness to understand HFDI plus standard care costs in
relationship to outcomes in relation to standard care alone. We will conduct a fully-powered, comparative
effectiveness RCT that includes 400 food insecure patients with T2DM. These patients will be recruited from
clinics serving rural populations. Patients will be randomly assigned to either the HFDI plus standard care or
standard care alone, with 200 in each arm. Baseline and follow up data (post-intervention, six months post-
intervention, and 12 months post-intervention) will be collected from patients in both study arms. The Healthy
Food Delivery intervention (HFDI) outcomes and findings will be applicable to vulnerable rural populations.
This proposal directly addresses NIH funding priorities related to food insecurity.32

Public health relevance
PUBLIC HEALTH RELEVANCE Rural US residents are at high risk for food insecurity and type 2 diabetes (T2DM).6,7 Recent studies have shown promise for improving health indicators for food insecure people with T2DM by distributing healthy food,22-24,29 but these interventions have not been tested in the rural populations who may benefit from the interventions the most. This study's objective is to determine whether a scalable, sustainable home food delivery intervention that is designed with rural food insecure patients with T2DM in mind can improve their health and diet quality.